Administrative Core

Project Summary
This Specialized Program of Research Excellence (SPORE) grant is intended to support multi-project,
interdisciplinary and multi-institutional translational research in glioma. The governance structure of this Dana-
Farber/Harvard Cancer Center (DF/HCC) SPORE grant provides the foundation for the implementation,
execution, and ultimate success of all projects and cores. The Administration Core serves as the “hub” for this
governance structure and aims to achieve a number of specific objectives as defined below. We will execute a
plan that provides experienced, centralized program leadership and administration. The Glioma SPORE
Director and Co-Directors are senior administrators, institutional leaders, and researchers who have worked
together on the current funding period for this SPORE and on prior DF/HCC initiatives and, consequently,
provide consistent, strong, complementary leadership for the grant. The trans-institutional administrative team
consists of senior personnel at DF/HCC institutions who have worked together effectively in the current and prior
funding periods of this grant. We include a senior clinical investigator in the Administration Core to supervise
Glioma SPORE- specific clinical trials, and to enable this Glioma SPORE to capitalize on existing DF/HCC P30
Cores to support these types of studies. We have established and utilized an effective internal and external
committee structure to provide multidisciplinary expertise, advice, and oversight of the program. Each of the
committees consists of collaborative, complementary members who have worked together in the current and
prior funding periods of this SPORE or on prior projects. A series of regular Glioma SPORE meetings involving
both administrative and scientific SPORE personnel will continue to facilitate close collaboration,
troubleshooting, and monitoring of the SPORE program. We will continue an effective internal and external
communications program, which includes a Glioma SPORE-specific component. An established and extensive
DF/HCC communications infrastructure is utilized to promote open, regular, trans-institutional communication
regarding SPORE opportunities and activities. We will reinforce an active SPORE program to enhance
participation by women and individuals underrepresented in medicine and science.

Public health relevance
Project Narrative Primary brain tumors are the third leading cause of cancer-related death among all persons 15-39 years of age. In the fullness of time, the work that we propose with targeted therapies could change the standard of care and improve adult and pediatric patients with gliomas. The Administration Core serves as the "hub" for the governance of this SPORE research program.